Estrogen Facilitation of Female Drug Relapse

? DESCRIPTION (provided by applicant): Across all stages of drug use and abuse, women exhibit heightened responsiveness and hence greater vulnerability to the properties of addictive drugs. This is especially true regarding the increased susceptibility women exhibit towards drug relapse. In women, maximal vulnerability peaks during the follicular phase of the menstrual cycle when estrogen levels are at their highest. These findings have been recapitulated in female rodents, where estradiol heightens multiple measures of drug responsiveness and abuse. The mechanisms by which estradiol mediates enhanced vulnerability to drug relapse are completely unknown. The two PIs of this proposal have been independently studying the neurological underpinnings of relapse, and the mechanisms by which estrogens affect neuronal activity. Now working together, we have generated a unifying theory, whereby estradiol activation of estrogen receptor α (ERα), localized to the surface membrane of medium spiny neurons of the nucleus accumbens shell (NAcSh), activates metabotropic glutamate receptor 1a (mGluR1a) signaling. Activation of ERα/mGluR1a signaling by estradiol is hypothesized to in turn promote mGluR5-induced relapse, a process mediated through the long-term depression of NAcSh afferents from the infralimbic cortex. To test this theory, the studies outlined in this proposal will utilize a recently developed mouse model of estradiol facilitation of drug relapse, taking advantage of electrophysiological, optogenetic and viral technologies. Collectively, these studies will provide a foundation to better understand and develop novel therapeutic approaches to treat drug relapse in women.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this proposal is to understand how estradiol imparts increased vulnerability to drug relapse in women. We hypothesize that in the nucleus accumbens shell, estrogen receptor α (ERα) activates signaling of metabotropic glutamate receptor 1a (mGluR1a), leading to alterations in neuronal connections, excitability and ultimately promoting behavioral changes that facilitate relapse potential. We propose to test this hypothesis and provide a novel means to disrupt ERα/mGluR1a signaling, thereby eliminating heightened female vulnerability to drug relapse and better understand the underlying neuronal mechanisms of relapse in general.